Informatics Research

Our overall mission is to derive actionable insights from integrating translational research data and to accelerate translation of findings into the clinic. Our efforts span the following general areas: 1) translational data analytics: development of custom workflows to interpret complex datasets such as multi-omic and clinical data, and application of data science approaches to predict translational research outcomes; 2) standards, knowledge sources, and software: connecting and supporting analyses of various types of experimental and curated datasets; in-house curation efforts; 3) scientific computing and research support: development, maintenance, and deployment of workflows, web and mobile apps to disseminate our robust methods and data. 4) rare disease informatics: developing an ontology for rare diseases, using natural language processing methods to draw up-to-date information on rare diseases from various sources (e.g., publications, grants, social media). These general areas are highly synergistic, where work one area informs work in other areas.